Emergency Myelopoiesis in the Pathogenesis of Myeloid Malignancies

PROJECT DESCRIPTION
Our overall goals are to understand how emergency myelopoiesis contributes to the pathogenesis of
myeloid malignancies, dissect the underlying metabolic and epigenetic mechanisms driving aberrant self-re-
newal and differentiation properties in malignant hematopoietic stem and progenitor cells (HSPC), and identify
potential vulnerabilities to target therapeutically. At steady-state, blood production reflects the differential pro-
duction by rare quiescent hematopoietic stem cells (HSC) of a small number of myeloid-biased multipotent pro-
genitors (MPP2/3) and a large number of lymphoid-biased multipotent progenitors (MPP4), which both give rise
to granulocyte/macrophage progenitors (GMP) and contribute to limited myeloid output. In contrast, during re-
generation, activated HSCs overproduce myeloid-biased MPP2/3, lymphoid-biased MPP4 are reprogrammed
towards myelopoiesis, and GMP expand in the bone marrow (BM) cavity as GMP clusters (cGMP), driving burst
production of myeloid cells. This remodeling of the HSPC compartment reflects the engagement of emergency
myelopoiesis pathways, which are transiently activated during regeneration but are co-opted and constantly
triggered in myeloid malignancies such as myeloproliferative neoplasms (MPN). However, the regulatory mech-
anisms controlling emergency myelopoiesis remain poorly understood, and the relationships between leukemic
myelopoiesis, which is continuously fueled by pre-leukemic HSCs in MPNs, and regenerative myelopoiesis,
which is an acute stress response, are still largely unexplored. Furthermore, the role of emergency myelopoiesis
in the development of acute myeloid leukemia (AML), where HSPC differentiation is blocked and leukemic stem
cells (LSC) emerges from transformed HSPCs, remains unknown. Our objective is to identify how HSPCs adapt
in these different situations and adjust both self-renewal and differentiation properties during regenerative and
leukemic myelopoiesis. In Aim 1, we will take advantage of our newly generated single-cell RNA sequencing
atlas of 5-fluorouracil (5FU)-mediated regeneration and Scl-tTA:TRE-BCR/ABL (BAtTA) MPN malignancy to iden-
tify changes in cell-state and differentiation trajectories driving activation of emergency myelopoiesis pathways.
In Aim 2, we will investigate the role of two key regulatory processes (metabolic adaptation and epigenetic
remodeling) in driving emergency myelopoiesis during regenerative and malignancy. In particular, we will test
the central role of the MYC transcription factor, the metabolite alpha-ketoglutarate (αKG) and the process of
glutaminolysis in remodeling the HSPC compartment. In Aim 3, we will test whether activation of emergency
myelopoiesis pathways cooperates with epigenetic driver mutations like TET2 loss in pre-leukemic HSCs to
promote clonal selection and LSC emergence from an expanded and remodeled HSPC compartment. Collec-
tively, these approaches will uncover the mechanisms driving emergency myelopoiesis that are critical for dis-
ease development, and provide new insights into the epigenetic and metabolic states associated with enhanced
myelopoiesis that could potentially be targeted for leukemia treatment.

Public health relevance
PROJECT NARRATIVE In addition to genetic driver mutations, activation of emergency myelopoiesis pathways in leukemic HSPCs contribute to the development of myeloid malignancies. The lack of a comprehensive understanding of how the specific biology and underlying molecular regulation of emergency myelopoiesis are altered in different leukemic contexts represents one of the major barriers to developing new therapeutics to treat myeloid maligan- cies. The overall goal of this project is to identify the transcriptional, epigenetic and metabolic mechanisms con- trolling emergency myelopoiesis and driving the overproduction of blast cells and clonal dominance of malignant HSPCs.